Volitional Control of the Nonhuman Primate Lower Limbs

SUMMARY
The ability to modify ongoing gait with precise, voluntary adjustments is what allows animals to navigate
complex terrains and to execute skilled actions during ongoing pursuits. However, how the nervous system
generates the signals to precisely control the lower limbs while simultaneously maintaining ongoing locomotion
is still poorly understood. While there is some consensus in the role of spinal cord (SC) central pattern
generators (CPGs) in the maintenance of locomotion, little is known about the role of primary motor cortex
(M1), especially in the case of volitional adjustments to ongoing locomotion movements. Our own work
suggests that M 1 plays at least a dual role in both the monitoring and the adjustment of the hindlimbs during
locomotor adjustments, expressed in different subspaces (manifolds) of its neuronal spiking activity. We
hypothesize that the emergence of these distinct neural subspaces plays a critical role in the dynamic
sensorimotor cortical control of locomotion. Specifically, the emergence of distinct low-dimensional subspaces
allows M1 to track sensed ongoing locomotion states, which are primarily driven by spinal-cord CPGs, and to
generate occasional descending motor commands to drive volitional adjustments without destructive
interference. Besides the basic neuroscience relevance, fully understanding the role of M1 in modulating
locomotion is essential for the development of new mobility therapies, including brain-machine interfaces
(BMls), for restoring walking and volitional leg control in people with paralysis. We have recently developed a
new experimental paradigm to test these hypotheses in nonhuman primates. It enables wireless recordings
from microelectrode arrays implanted in multiple sensorimotor cortical areas during natural locomotion and
navigation around obstacles visually cued on a treadmill and other spaces. In addition to M 1, we plan to
simultaneously record primary sensorimotor cortex (S1) and lower limb electromyography (EMG), while
actively probing M1-S1-SC interactions via cortical and spinal electrical stimulation. There are 3 specific aims.
AIM 1: To test the hypothesis that information streams necessary for the control of ongoing locomotion and
volitional adjustments are coordinated in motor cortex activity via the emergence of distinct neural subspaces.
AIM 2: To test the hypothesis that specific subspaces emerge to coordinate the bidirectional interactions
between M 1 and S 1 during sensorimotor control of ongoing locomotion and volitional adjustments. Finally, we
have previously shown that neural decoders trained on ongoing locomotion do not generalize to the decoding
of volitional adjustments, thus motivating AIM 3: To develop adaptive BM I neural decoding approaches for
locomotion under distinct regimes of sensorimotor cortical control. PUBLIC/HEALTH/RELEVANCE: This
research's long-term goal is the restoration of movement in people with paralysis. The project will advance the
understanding of sensorimotor control of locomotion and lead to better BM Is for restoring walking ability in
humans with spinal cord injury due to partial damage of ascending and descending pathways.

Public health relevance
NARRATIVE This research project aims at determining how sensorimotor cortex in nonhuman primates contributes to the control of volitional adjustments to locomotion in an adaptive manner. The ability to modify gait with precise, voluntary adjustments is what allows animals to navigate complex terrains and to execute skilled actions during ongoing pursuits. Beyond the relevance to the basic neuroscience of sensorimotor control of locomotion, the aims of the project are essential for the development of new mobility therapies, including brain-machine interfaces, for restoring walking and volitional leg control in people with paralysis.